ENERGY BALANCE AND METABOLIC EFFECT OF EXERCISE IN WOMEN WITH NIDDM

The goal of this study is to determine whether beneficial effects of exercise on insulin sensitivity are due to changes in energy balance. Basal and insulin-stimulated glucose metabolism in obese women with mild non-insulin dependent diabetes mellitus are measured.